WHOLE BODY MEASUREMENTS OF BONE AND SOFT TISSUE BY DEXA

The objective of this study is to compare the two instruments (these are the two major instruments currently in use) listed for the measurement of bone mineral density and soft tissue readings. This is being performed to evaluate the methods for the next NHANES data collection effort. The investigator has been asked by the National Center for Health Statistics to perform this comparison. Fifty individuals aged 20-80 will be studied at this site (an addition 50 from USCF will also be studied). Same day scans will be performed. The data analysis is clearly outlined and based on correspondence attached to the protocol, the power to detect significant differences is present. This study was successfully completed. All volunteers were entered and the data analyzed. This data is used to help the National Health Examination Survey determine whether to use hologic dual energy x-ray absorptiometry equipment to perform body composition analysis in the next NHANES Survey.